Animal Model & Clinical Core

ABSTRACT: Core C is designed to provide PPG investigators with rigorously defined and reproducible novel
ovine models of congenital heart disease (CHD) using fetal cardiac surgical techniques. To this end, Core C will
comprehensively generate, manage, and provide all animal-related experiments, resources, and expertise. In
addition, Core C has previously obtained peri-operative blood samples from neonates, infants, children, and
adults with a wide range of differing congenital heart defects that can be utilized by PPG investigators. A secure
database has already been established that contains banked samples and clinical data on >500 patients. Core
C will be defined in this context by providing five services: 1) Ovine models of CHD. This will include our well-
established Shunt model and our newly created Post Shunt Closure model. Tissues (peripheral lung and
isolated vessels) and primary pulmonary artery endothelial and smooth muscle cells (both proximal and
microvascular) will be available to PPG investigators. 2) Acquisition and analysis of data. This will include the
evaluation of invasive and non-invasive cardiopulmonary hemodynamics, including sophisticated ventricular
function indices, pulmonary vascular reactivity (both in vivo and ex vivo), the assessment of pulmonary vascular
remodeling, advanced in vivo imaging, that includes echocardiography, computed tomography (CT) and MRI
cardiopulmonary imaging, cardiac catheterization, formal pulmonary function testing, and cardiopulmonary
exercise testing. 3) Biochemical, proliferation, apoptosis, and angiogenesis determinations. This will include the
measurement of various reactive oxygen, nitric oxide metabolites (NOx) and nitrogen species of oxygen or
nitrogen oxide in vascular cells and tissues, indices of cell proliferation, apoptosis, and tube formation. 4) Use of
medicinal chemistry to generate novel therapeutic agents. 5) A biorepository and corresponding clinical database
of neonates, infants, children, and adults with CHD. Blood samples from patients with CHD were obtained before
and after surgical repair for human confirmation of aberrant pathways initially identified in animals and for
metabolic screening. Correlation between the identified aberrations, with the type of CHD (+/- flow; +/- pressure),
and the degree of pre-operative and post-operative pulmonary vascular disease will be sought. Core C will
enhance the scientific work for all three projects by assuring that all animal models are standardized and
performed uniformly by highly experienced and trained personnel. Tissues and cells from these models will also
be used for bulk and single-cell transcriptomics. Investigators with many years of experience using these
techniques run Core C. They have developed or adapted several techniques and applied them to perform
physiological studies in vitro, ex-vivo, and in vivo systems. As a central dedicated analytical resource, Core C
will ensure that these analyses are carried out cost-efficiently with minimal animal morbidity and mortality. Sex
as a biological variable will also be explored throughout the Core.

Public health relevance
RELEVANCE: Congenital Heart Disease (CHD) remains one of the most common worldwide causes of PVD, and represents 45-55% of all pediatric PVD. The current proposal is based on large animal, clinically relevant models of CHD that result in abnormal pulmonary blood flow (PBF) patterns and early PVD. These unique ovine models require complex fetal cardiac surgical techniques and sophisticated hemodynamic monitoring. As these services are best centralized given their inherent difficulty, rely on specialized and sophisticated equipment and expertise, and the individual project requirements, Core C will provide these services for all three projects.